DIVISION OF CANCER PREVENTION, INFORMATION TECHNOLOGY AND INFORMATICS SUPPORT

This requirement provides information Technology and Informatics support for Division of Cancer Prevention (DCP) (e.g., database administration, data reporting, SharePoint administration, and other informatics programming).